RNAi-dependent epimutation roles in antimicrobial drug resistance and pathogenesis

Abstract. This proposal focuses on the human fungal pathogenic Mucor species complex, a group of related
pathogens that cause devastating infections that are difficult to treat, with limited drug treatment options, and
requiring surgical debridement in some patients. Over the past decade, we and others have advanced genomics,
genetics, and animal models for this understudied group of microbial pathogens. We discovered the protein
phosphatase calcineurin controls the dimorphic transition from yeast to hyphae required for Mucor pathogenesis,
and through studies of FK506-resistant isolates discovered a novel mechanism of antimicrobial drug resistance.
In previously published and preliminary studies, significant advances were achieved through our discovery
of a novel mechanism of antifungal drug resistance called epimutation, whereby the RNAi pathway is activated
and silences drug target genes. This pathway confers transient, unstable drug resistance, and resistant isolates
rapidly revert to drug sensitivity in the absence of drug. Through genetic and molecular studies, we defined
RNAi components required for epimutation, those that are dispensable for epimutation, and a novel category
that inhibits formation of epimutations. The discovery of antimicrobial drug resistance mediated via epimutations
has been generalized: 1) showing epimutation occurs in two different pathogenic Mucor species, 2) defining an
alternative RNAi pathway controlling epimutation frequency and stability, 3) identifying epimutations in additional
genes causing resistance to antifungal agents, and 4) documenting that epimutations persist during animal
infection or arise after animal passage. These insights set the stage for studies proposed here to further define
mechanisms of epimutation, and elucidate the impact of epimutations on microbial pathogen interactions with
the host. In the current proposal, we hypothesize epimutation is a general process that operates across many
eukaryotic microbial pathogens, and acts as a major force in antimicrobial drug resistance that controls target
genes involved in drug action, genome stability, and pathogenesis of eukaryotic microbial pathogens.
Our studies will reveal unique facets of RNAi that lead to epimutations, which mediate antimicrobial drug
resistance in ubiquitous fungal pathogens of humans. Aim 1 will 1) elucidate molecular mechanisms of
epimutation and targets, including genes involved in drug resistance (including clinically used antifungal drugs)
and transposable elements, and their impact on genome stability, 2) define conditions, including stress, sexual
reproduction, and infection, that may drive the emergence of epimutations, and 3) establish the generalizability
of these findings to other pathogenic fungal species. Aim 2 will define the impact of epimutation on antimicrobial
drug resistance and pathogenicity in microbe interactions with immune cells, the blood-brain barrier, organoids,
and whole-animal models. These studies will advance our understanding of how antimicrobial drug resistance
can evolve via a novel RNAi-based pathway with direct implications for infectious disease evolution, treatment,
and prevention, and provide insights into other eukaryotic pathogens with active RNAi pathways.

Public health relevance
NARRATIVE This proposal focuses on the fungal pathogenic Mucor species complex, which includes zygomycete pathogens that cause devastating infections in humans that are difficult to treat, with limited drug treatment options, and requiring surgical debridement in some patients. In this proposal, we aim to elucidate the molecular mechanisms and targets of epimutation, a novel mechanism of antimicrobial drug resistance in which RNAi silences drug target genes, and define the impact of host-pathogen interactions on epimutation. Results from these studies will inform treatment and prevention strategies for patients afflicted with Mucor infections by providing insights into novel mechanisms of pathogenesis and resistance to antifungal drugs as well as by stimulating development of novel antifungal drugs.